Decoding the Neural Representations of Movement Minimally Invasively via Functional Ultrasound

PROJECT SUMMARY/ABSTRACT
Neurological conditions such as spinal cord injury and ALS severely impair patient function, leaving many
patients paralyzed. Brain-machine interfaces (BMIs) offer patients the ability to restore their autonomy by
translating brain signals into actionable outputs. However, current neurorecording techniques commonly
require invasive surgical implantation and are constrained by technical limitations, sacrificing spatiotemporal
resolution for field of view and vice versa. These constraints hinder our understanding of motor variable
encoding in the primary motor cortex (M1) and posterior parietal cortex (PPC). Functional ultrasound (fUS), a
novel neuroimaging technique, offers a solution by minimally invasively providing high spatial resolution (<300
um), sensitivity (~100 ms), and large plane of view (several cm) for recording neural activity at a mesoscopic
scale from outside the dura. This proposal aims to leverage fUS to clarify the representations of motor
variables such as movement effector and trajectory in M1 and PPC and develop a minimally invasive motor
BMI that can restore functionality to patients with motor disabilities. Specific Aim 1 seeks to identify the
mesoscopic neural representations of motor execution and planning across different effectors in M1 and PPC
respectively, key areas commonly targeted in motor BMIs. To do so, we will record fUS data from human
participants with sonolucent cranial implants as they perform instructed delay motor tasks using various
movement effectors such as fingers, arm, leg, and face. This will generate a mesoscopic mapping of effector
representation across both M1 and PPC, bridging microscopic and macroscopic motor encoding. Specific Aim
2 builds on these findings and investigates the neural encoding of movement trajectory in M1 and PPC to
develop a real-time fUS-based motor BMI capable of predicting movement direction for cursor control. We will
first use an instructed delay task using 8 different directions of hand and arm movement to discern the basic
encoding of movement trajectory in M1 and PPC and then decode trajectory on a continuous scale, using a
target tracking task for real-time BMI cursor control. Specific Aim 3 will examine the relationship between
neurovascular signal and single-neuron activity by comparing fUS signal to prior recorded single-unit activity
from Utah electrode arrays. This will help validate our fUS findings in Aim 1 and Aim 2, further establishing
fUS as a robust neuroimaging technique that can be used in place of electrophysiology, and elucidate the
transfer functions between single-neuron activity and neurovascular changes in cerebral blood volume.
Altogether, this proposal will provide a better understanding of motor variable encoding in the cortex, providing
crucial information that can be used for more effective BMI design. This will validate the abilities of fUS both as
a neurorecording technique and as a minimally invasive BMI alternative. These findings have the potential to
expand the accessibility of BMIs and enable further development of fUS for more widespread clinical
applications such as chronic neuropsychiatric monitoring and closed-loop neuromodulation.

Public health relevance
PROJECT NARRATIVE Brain machine interfaces (BMIs) offer patients suffering from neurological injury and disorder the ability to regain their autonomy by providing control of assistive devices using their thoughts. Current BMIs are constrained by the requirement of invasive surgical implantation and the technical limitations of current neurorecording techniques, limiting the patient pool able to access BMIs and our understanding of motor variable encoding at the mesoscopic level. This study aims to use the novel neurotechnology, functional ultrasound (fUS), coupled with electrophysiology to bridge our understanding of macroscopic and microscopic motor representation in the primary motor cortex and posterior parietal cortex and expand the accessibility of BMIs through the development of a more minimally invasive fUS-based motor BMI, demonstrating fUS’ potential for future clinical applications such as chronic neuropsychiatric monitoring and closed-loop neuromodulation.